Phage/Salmonella interactions during oxidative stress

PROJECT ABSTRACT
Nontyphoidal Salmonella are responsible for about 180 million cases of diarrhea and 300,000 deaths a
year globally. Very young and very old people, cancer patients, immunocompromised individuals coinfected
with HIV, and chronic granulomatous disease (CGD) patients bearing inactivating mutations in the
phagocyte NADPH oxidase are some of the populations that are at high risk from suffering disseminated
nontyphoidal Salmonella infections. The high susceptibility of CGD patients to disseminated nontyphoidal
salmonellosis attest to the role reactive oxygen species produced in the respiratory burst of macrophages
play in resistance to this facultative enteropathogen. We still have profound gaps in knowledge regarding the
mechanisms by which reactive oxygen species mediate antimicrobial activity. Reactive oxygen species
directly damage a variety of biomolecules. We have made the unprecedented discovey that reactive oxygen
species produced by host phagocytic cells exert potent anti-Salmonella activity by inducing expression of the
Gifsy-1 prophage terminase. The Gifsy-1 terminase gains unprecedented tRNase activity upon oxidation of
cysteine residues forming a structural zinc finger. The oxidation of Gifsy-1 terminase results in the redox-
dependent cleavage of the anticodon loop of tRNALeu. This is a very unexpected finding if we consider that the
canonical functions of phage terminases are to cleave phage DNA and load the resulting single genomes into
preformed viral capsids. Cumulatively, our data support the hypothesis that the oxidation of redox active
cysteine residues in the zinc finger of the Gifsy-1 terminase stimulates the formation of an oligomer with
tRNase activity, thus sensitizing Salmonella to the phagocyte NADPH oxidase. Aim 1 will characterize the
mechanism by which gpA senses oxidative stress. Aim 2 will identify the mechanism by which oxidized gpA
gains tRNase activity. Aim 3 will reveal the determinants responsible for the selective cleavage of tRNALeu by
oxidized gpA. The knowledge generated using a combination of synergistic biophysics, biochemistry,
bioinformatics, bacteriology, as well as bacterial and mouse genetics will illuminate key aspects of
Salmonella pathogenesis, while providing a new framework for understanding the strategies used by
bacteriophages to subvert their bacterial hosts during the mammalian immune response. Terminases are
highly conserved in evolutionarily distant phages and herpesviruses. Hence, the knowledge gained in our
investigations may be applicable to phylogenetically diverse prokaryotic and human viruses.

Public health relevance
PROJECT NARRATIVE Bacteriophage-encoded toxins impart disease-promoting traits to human pathogens such as Shigella dysenteriae or Clostridium botulinum. We have discovered that a phage terminase involved with processing and packaging of phage DNA becomes a toxin that damages Salmonella tRNA molecules under oxidative stress conditions. Because terminases are conserved in phylogenetically diverse bacteriophages, the proposed work will increase our understanding of bacterial phage interactions during oxidative stress.